Role of anterior olfactory nucleus for multi-sensory integration in the olfactory system

Project Summary
Sensory signals encountered under different circumstances may have quite different implications. In the
early olfactory system, preliminary evidence suggests that this (non-olfactory) contextual information is
integrated into odor representations at a very early stage, potentially even the main olfactory bulb. Recent
evidence indicates that the anterior olfactory nucleus (AON), a structure directly adjoining the olfactory bulb,
serves to integrate afferent odor information with contextual information from the ventral hippocampus
(vHC) and is necessary to solve contextually-dependent olfactory decision-making tasks.
The vHC is known to relay task-relevant spatial contextual information to other brain systems. We here
hypothesize that direct projections from the vHC to the AON play a dominant role in the integration of
contextual and olfactory information, and that the AON embeds this multisensory contextual information into
early-stage odor representations. Our preliminary data show that rodents can learn to respond differently to
odors based on the spatial context in which they are encountered, and that the expression of such a rule
depends on both AON and vHC, whereas a similar but odor-independent task requires vHC but not AON.
We propose a multipronged approach to understanding the integration of spatial context into olfactory
representations, engaging electrophysiological ensemble recordings and interareal coherence
measurements in awake, behaving rodents, the optogenetic manipulation of vHC and AON circuit activities,
and a double-labeling strategy for the within-subjects comparison of immediate-early gene (Fos) responses
across two experimental conditions separated in time.
Supplement summary: Piriform cortex (PC), is tightly interconnected with OB, AON and vHC and
potentially involved in similar processed. The additional Aims planned include testing the hypothesis that PC
performs complementary functions to AON and is involved in contextual processing.

Public health relevance
Project Narrative This research investigates how physical or behavioral context can influence our perception of the world around us. Malfunctions of these interactions can lead to maladaptive behaviors exhibited by mental health patients and patients with severe trauma. In particular, the direct integration of context into basic early sensory signals in the brain suggests a deep entanglement that may warrant changes to desensitization strategies for treating post-traumatic stress disorders.